Advancing Clinical Research Training within Addiction Residency Programs

PROJECT SUMMARY
In 2016, the American Board of Medical Specialties (ABMS) recognized Addiction Medicine as a new
subspecialty. In anticipation of this, and to assure that the development of this field would include physicians
committed to addiction research, the Research in Addiction Medicine Scholars (RAMS) Program was created
in 2012 with this original NIDA R-25 award. The paucity of well-trained addiction physician researchers limits
scientific advancement, risking missed opportunities to explore optimal approaches to care for patients with
substance use disorders. Furthermore, physicians trained in Addiction Medicine must be poised to provide
leadership related to their expertise in their academic medical centers and communities. The RAMS Program
seeks to continue and improve on its mission to strengthen the next generation of addiction physician
researchers and leaders in healthcare. Currently US fellowship programs exist in both Addiction Medicine
(n=41) and Addiction Psychiatry (n=45). These fellows are the source of RAM Scholars as the program takes
place during fellowship training. In this renewal application, we continue and enhance the mission of the RAMS
Program to bolster addiction research training for fellows at local fellowship sites with a combination of
intensive annual in-person trainings in Boston and at the College of Problems of Drug Dependence (CPDD)
national conference as well as in monthly webinars. The RAMS Program supports a new cadre of addiction
physician researchers by meaningfully encouraging physician careers in addiction research through training
and mentorship. The Program Directors (PDs) and staff will pursue the following Specific Aims:
1) Provide clinical research training over 2 years to 5 addiction subspecialty physicians (RAM
Scholars) and over 1 year to 1-2 chief residents (Junior Scholars) interested in addiction research,
selected annually, through retreats, webinars, and research-in-progress sessions.
2) Augment institutional mentoring of addiction subspecialty physicians on research projects and
career trajectory by establishing mentorship relationships between Scholars and nationally recognized
researchers (RAMS National Advisory Committee [NAC]) and the RAMS Program research methodologist.
3 Provide leadership training for addiction subspecialty physicians (RAM Scholars) by introducing
physicians to the concepts and skills necessary for future academic leadership roles within organizations and
community.
The Research in Addiction Medicine Scholars (RAMS) Program will accelerate the progress of its important
mission of developing the next generation of addiction physician researchers in order to advance the
knowledge base to provide better care for patients with, and at risk for, addictive diseases, by supporting
trainees as the clinical training of addiction physicians continues to expand nationally.

Public health relevance
PROJECT NARRATIVE The Research in Addiction Medicine Scholars (RAMS) Program is significant because it engages trainees who are future leaders and clinical researchers in the expanding subspecialty training of addiction medicine, seeking to improve patient care and reduce the medical, social, and financial burden of people with, and at risk for, substance use disorders.